Multimodal machine learning for diagnosis and mechanistic phenotyping of inherited diseases

ABSTRACT
Inherited diseases frequently manifest with distinctive facial features, collectively referred to as the “facial
gestalt.” However, the effectiveness of using facial information relies heavily upon the clinician's breadth of
experience, and such reliance often leads to delays in diagnosing patients. Furthermore, 1 in 600 newborns
have craniofacial anomalies, impacting the skull, jaws, ears and/or teeth. Improved therapeutic approaches
require a deep understanding of the molecular and biological systems underlying these craniofacial conditions.
Through an interdisciplinary and agile team, our study has two objectives: (1) We will develop an ethically
focused and data-driven multimodal machine learning algorithm that integrates frontal facial photos, clinical
notes, patient demographics, and structured phenotypes to improve diagnosis of genetic syndromes. (2) We
will develop a multimodal algorithm that takes 4D videos (non-invasive laser scanning to map craniofacial
surface morphology), facial photos, electronic health records, and omics information (genome, transcriptome
and epigenome), to prioritize genes in key pathways that are relevant to phenotypic features of craniofacial
abnormalities. We will adapt a patient/clinician engaged design, ensuring that the training data and outcome
evaluation metrics align closely with real-world applications. We will develop a modularized open-source
software to decouple the multimodal approach from the underlying pretrained models, ensuring that the final
product is adaptable to rapid changes in AI technologies to be easily integrated into evolving healthcare
landscapes. Our project addresses the social-technological challenges in clinical diagnosis of rare diseases, to
advance understanding, interpretation and prediction of complex biological, behavioral, and health
manifestations through the implementation of multimodal approaches.

Public health relevance
Rare genetic diseases collectively affect 300 million individuals worldwide, yet many patients experience prolonged diagnostic delays and limited understanding of the biological mechanisms underlying their conditions. This project will develop multimodal artificial intelligence tools that combine facial images, clinical features, and genomic information to improve diagnostic accuracy, uncover disease mechanisms, and ultimately support more timely diagnoses and precision medicine approaches for affected patients.